Community Engagement Core

PROJECT SUMMARY/ABSTRACT – COMMUNITY ENGAGEMENT CORE (CEC)
The STEEP Community Engagement Core (CEC) will address community concerns about per- and polyfluoro-
alkyl substances (PFAS), with a goal of developing intervention strategies to reduce exposures and prevent
adverse health outcomes. CEC activities will center on Cape Cod, MA, where the sole source aquifer, which
provides drinking water to 200000 year-round and 500000 summer residents, has been contaminated by
aqueous film forming foam (AFFF) use at a municipal fire training academy, military base, airport, and other
locations. Initial findings from STEEP’s private wells study suggest domestic wastewater entering groundwater
from septic systems also can be a source of PFAS to private wells on Cape Cod. While public and private drinking
water wells with PFAS levels above health guidelines are now being treated for PFAS, environmental exposures
may remain elevated from consumption of locally grown produce in areas with historical drinking water
contamination and consumption of fish and shellfish in areas with contaminated surface waters.
CEC will strengthen and extend existing bidirectional connections throughout Cape Cod to address local
concerns, increase public awareness, and develop intervention strategies to reduce PFAS exposures. CEC will
continue to engage with town and county health officials, water suppliers, environmental NGOs, and residents.
Bidirectional approaches will include holding focus groups with target communities, hosting STEEP community
update events, participating in community events throughout Cape Cod, and serving as a resource to inform
decision making processes. CEC will work with the Administrative Core (AC) on research translation to develop
informational materials and continue to engage with local media to reach a broad audience. CEC will extend its
partnership with the Mashpee-Wampanoag Tribe to evaluate exposures among tribal members and develop
culturally specific risk reduction strategies. STEEP trainees will connect with high school teachers to educate
students about PFAS and other pollutants and inspire their interest in protecting water quality.
Aim 1: Address community concerns about PFAS exposures from environmental sources by offering a testing
program for homegrown produce and locally caught fish and shellfish and supporting STEEP’s extended
exposure assessment in Hyannis.
Aim 2: Collaborate with the Mashpee Wampanoag Tribe to collect fish, shellfish, and well water for PFAS
analysis, develop identity-based messaging strategies to communicate PFAS risks with tribal members, and
evaluate the effectiveness of various messages and delivery channels to reduce PFAS exposures.
Aim 3: Connect STEEP trainees with high schools on Cape Cod to enhance understanding of PFAS and other
water quality issues through supplemental curriculum and Cape-wide high school water quality summits.
Aim 4: Collaborate with community organizations on Cape Cod and more broadly to educate and empower
communities affected by PFAS contamination.

Public health relevance
PROJECT NARRATIVE – COMMUNITY ENGAGEMENT CORE (CEC) The Community Engagement Core (CEC) will address community concerns on Cape Cod, Massachusetts, about per- and polyfluoroalkyl substances (PFAS), with a goal of identifying local sources of PFAS exposures and developing intervention strategies to reduce these exposures and prevent adverse health outcomes. CEC will foster bidirectional partnerships with local water and health officials, members of the Mashpee Wampanoag Tribe, high school teachers and students, environmental nonprofit organizations, and other concerned residents through focus groups, community events, a community advisory committee, and resident participation in the design and implementation of a sampling program for local foods. CEC will advance public health by potentially reducing exposures to PFAS from the local environment, by providing new information about sources of PFAS exposure, and by supporting decision making by local, state, and federal water and health agencies.